Postdoctoral Research Associate Training Program (PRAT)

The NIGMS Postdoctoral Research Associate Training (PRAT) Program's overarching goal is to provide high quality postdoctoral research training in the basic biomedical sciences, in NIH intramural research laboratories, to a diverse group of postdoctoral fellows to prepare them for leadership positions in biomedical careers. The research projects focus on NIGMS mission-related areas of basic biomedical science. These include biological chemistry, biophysics, bioinformatics, cellular and molecular biology, developmental biology, genetics, immunology, neuroscience, pharmacology, physiology, and technology development. Studies employing a variety of research organisms are encouraged. Publications are included as part of the IR research mentor's reports. All PRAT Fellows are IRTAs. PRAT Fellows and Preceptors, Class of 2018, effective September 1, 2018: Marina Feric, PhD Tom Misteli, PhD (NCI) Adenrele Gleason, PhD Julie Cooper, PhD (NCI) (2018 - 2019) Ellen Sidransky, MD (NHGRI) (2020) Tanner Chase Francis, PhD Antonello Bonci, MD (NIDA) (2018) Marisela Morales, PhD (NIDA) (2019 - 2020) David Reiner, PhD Yavin Shaham, PhD (NIDA) Apollo Stacy, PhD Yasmine Belkaid, PhD (NIAID) Agnes Karasik, PhD Nicholas Guydosh, PhD (NIDDK) Sofia Beas-Parodi, PhD Mario Penzo, PhD (NIMH) PRAT Fellows and Preceptors, Class of 2019, effective September 1, 2019: Jacquelyn Evans, PhD Elaine Ostrander, PhD (NHGRI) Sofiya Hupalo, PhD Joshua Gordon, PhD (NINDS) Nathan Williamson, PhD Peter Basser, PhD (NICHD) James Marks, PhD Markus Hafner, PhD (NIAMS) Philip Adams, PhD Gisela Storz, PhD (NICHD) Vivien Maltez, PhD Ronald Germain, PhD (NIAID) Elizabeth Martin, PhD Paul Wade, PhD (NIEHS) Mahamat Babagana, PhD Myong-Hee Sung, PhD (NIA) PRAT Fellows and Preceptors, Class of 2020, effective September 1, 2020: Tiffany Zarrella, PhD Anupama Khare, PhD (NCI) Pam Head, PhD Charles Venditti, MD, PhD (NHGRI) Sezen Meydan-Marks, PhD Nicholas Guydosh, PhD (NIDDK) Danielle Chisolm, PhD Markus Hafner, PhD (NIAMS) Evan Hart, PhD Geoffrey Schoenbaum, MD, PhD (NIDA) Marcos Ramos-Benitez, PhD Daniel Chertow, MD, MPH (CC) Omar Soler-Cedeno, PhD Yarimar Carrasquillo-Garcia, PhD (NCCIH) (2020) Zheng-Xiong Xi, MD, PhD (NIDA) (2021) Andrew Moehlman, PhD Richard Youle, PhD (NINDS) Andrew Beaven, PhD Alexander Sodt, PhD (NICHD) Rachael Philips, PhD John O'Shea, MD (NIAMS) PRAT Fellows and Preceptors, Class of 2021, effective September 1, 2021: Britney Hardy, PhD Anupama Khare, PhD/Kumaran Ramamurthi, PhD (NCI) Luis Colon-Cruz, PhD Shawn Burgess, PhD (NHGRI) Rachel Cosby, PhD Todd Macfarlan, PhD (NICHD) Aisha Burton, PhD Gisela Storz, PhD (NICHD) Veronica Ryan, PhD Michael Ward, MD, PhD (NINDS) Rodolfo Flores-Garcia, PhD Hugo Tejeda, PhD (NIMH) Saniya Rattan, PhD Humphrey Yao, PhD (NIEHS) Liz Garcia-Peterson, PhD Xiaoling Li, PhD (NIEHS)